Phase II Clinical Trial to Evaluate a Vaccine for Gonorrhea

This IAA seeks to support the protocol development, clinical trial implementation, close out and analysis of a phase 2 clinical trial to evaluate the efficacy of the Bexsero vaccine in preventing Neisseria gonorrhoeae (Ng) infection, which can become resistant.